Health informatics approaches to reduce missed opportunities in diagnosis of pancreatic cancer

Background. Pancreatic cancer is a highly lethal cancer with increasing incidence among Veterans.
Early diagnosis offers the best chance of survival, yet only 30% of Veterans with pancreatic cancer are diagnosed
at early stages. Our proposal focuses on optimizing early diagnosis of patients with clinical findings suggestive
of pancreatic cancer who are at risk for delayed diagnosis through identifying and reducing missed opportunities
in diagnosis (MODs). MODs are defined as instances in which post-hoc judgement indicates that alternative
decisions or actions could have led to a more timely diagnosis.
Significance/Impact. This proposal is centered around the VA HSR&D priority areas of quality and
safety and health care informatics. There are few systematic efforts to improve quality of cancer care for Veterans
with pancreatic cancer. This proposal is one of the first large-scale efforts to examine the gaps in care for these
patients. We propose to develop electronic trigger tools that, when implemented, will have the potential to identify
possible missed opportunities to either initiate or complete the diagnostic process for earlier pancreatic cancer
diagnosis. Our results will also serve as foundational for developing informatics-based diagnosis tools for several
other high-risk conditions, including other cancer types.
Innovation. The development of novel decision support tools (e-triggers) to reduce diagnostic delays in
pancreatic cancer represents the first e-trigger tool that is centered on pancreatic cancer care and built around
a constellation or combination of “red flags” as opposed to a single “red flag” as in all prior works on the topic.
Our study is also conceptually innovative because it represent a first step towards moving e-trigger tools to
reduce diagnostic delays in pancreatic cancer from the research environment into the clinical setting.
Specific Aims. Our goal is to improve the diagnostic process for pancreatic cancer by developing
effective decision support tools. We have 3 aims. Aim 1: To identify missed opportunities for pancreatic cancer
diagnosis. Aim 2: To develop electronic algorithms (i.e., e-trigger tools) to identify high-risk Veterans with
potential missed opportunities for pancreatic cancer diagnosis. Aim 3: To conduct a formative assessment of e-
trigger tools to guide future testing and implementation in clinical practice.
Methodology. In Aim 1, we will randomly select 500 pancreatic cancer cases from an already
established national VA cohort for structured review of their medical records to identify the frequency and types
of MODs as well as key patient-, provider-, and system-specific factors linked to these missed opportunities. In
Aim 2, based on the findings of Aim 1 and what is known from the literature, we will develop up to 5 e-trigger
tools to identify patients at high-risk for potential MODs through automated identification of specific patterns in
clinical electronic health record data. In Aim 3 we will perform formative assessment through stakeholder
interviews with Veterans, health care providers, and operational personnel to identify barriers and facilitators to
implementing developed e-triggers in clinical practice, as well as a host of socio-technical factors.
Implementation/Next Steps. The proposed research will develop health care informatics tools to identify
opportunities for earlier pancreatic cancer diagnosis among high-risk patient subgroups who warrant diagnostic
evaluation. In the next steps, we will examine the effectiveness of our informatics tools (e-trigger tools) to improve
quality of pancreatic cancer care in the VA through a hybrid type I effectiveness-implementation study. This
multidisciplinary research, along with career development and mentoring plans, will increase knowledge of earlier
cancer diagnosis opportunities in the VA and enhance my ability to transition to an independent health services
researcher with expertise in health care informatics. The VA is the largest provider of cancer care in the U.S.,
thus providing the ideal setting for developing and implementing new ways to optimize diagnostic processes in
cancer care.

Public health relevance
Pancreatic cancer is a deadly cancer with increasing incidence for which no systematic efforts to reduce diagnostic delays exist. Our preliminary work shows that 40% of Veterans with pancreatic cancer experience diagnostic delays of  90 days and 40% experience missed opportunities to initiate or complete their diagnostic evaluation in a timely manner. Opportunities for more timely diagnosis of pancreatic cancer are possible in the VA, and the work put forth in this proposal tries to identify and transform these opportunities into decision support tools. In this project, we will: (1) identify potential missed opportunities for pancreatic cancer diagnosis; (2) develop electronic trigger (e-trigger) tools aimed at identifying high-risk patients with potential missed opportunities for pancreatic cancer diagnosis; and (3) assess local stakeholders’ views of facilitators and barriers to implementation of e-triggers for future application in clinical practice. These aims will be aligned with career development and training activities including formal coursework and a structured mentorship plan.